Spatial Organization of the Oral Microbiome

TITLE: Spatial Organization of the Oral Microbiome
PI: Jessica Mark Welch
Project Summary/Abstract
Bacteria colonizing the human mouth play important roles not only in oral health, but in systemic health
and disease. This proposal addresses the key unsolved question of how spatial organization of the oral
microbiota is connected to its function at the micron scale. Our previous work pioneered the imaging of oral
microbiome biogeography by developing a Combinatorial Labeling And Spectral Imaging - Fluorescence in situ
Hybridization (CLASI-FISH) strategy to analyze the micron-scale architecture of microbial communities at a
systems level. In this project we build on these findings to investigate structure-function relationships, assess
complexity of consortia at micrometer scales within single human hosts, and develop multiplexed live cell
imaging to study the dynamics of multispecies in vitro biofilms at the single-cell level.
In Aim 1 we investigate how a key parameter of host-microbiome interaction, salivary nitrate
concentration, affects the structure of the bacterial biofilm on the tongue dorsum. The nitrate-reducing
capability of bacteria on the tongue plays a major role in the generation of nitric oxide, which impacts
vasodilation and control of blood pressure. In turn, the secretion of nitrate into saliva by salivary glands affects
the metabolism and composition of the tongue microbiota. Using dietary nitrate supplementation of volunteers,
we will quantify the spatial organization of nitrate-metabolizing taxa in tongue biofilm consortia that developed
in high and low salivary nitrate concentrations, and we will use whole-genome shotgun sequence data to
determine which species and strains are responsive to nitrate.
In Aim 2 we address an almost entirely unexplored question: in micron-scale neighborhoods in the oral
microbiome, does each species function as a clone or as a complex mixture of strains? The answer to this
question is important for learning to manipulate and modulate the oral microbiome and determining whether,
for purposes such as microbiome transplants or building an in vitro biofilm model, a single strain is an
adequate representative of the community. We will address this question by microdissection of single tongue
dorsum consortia 100-200 micrometers in diameter, followed by whole-genome shotgun sequencing and
analysis to assess whether natural oral consortia are made up of clones or complex populations.
Live imaging is a powerful method of analysis of taxon-taxon interactions, but multiplexed live imaging
of bacteria with single-cell resolution has been almost entirely absent from studies of the oral microbiome. The
goal of Aim 3 is to develop a live-imaging system, using vital dyes, to differentiate up to 6 taxa within live
simplified communities. We will use this system to investigate the dynamics of taxon-taxon interactions in
consortia representing components of dental plaque and the tongue biofilm. Our goal is to learn how members
of the oral microbiome respond to one another under controlled conditions, and to evaluate whether these in
vitro systems develop spatial organization resembling those of natural communities.

Public health relevance
TITLE: Spatial Organization of the Oral Microbiome Project Narrative: Bacteria colonizing the human mouth play important roles not only in oral health, but in systemic health and disease. This project addresses the key unsolved question of how micrometer-scale spatial organization of the oral microbiota is connected to its function. We will investigate how the spatial structure of bacterial communities affects their response to dietary nitrate, will determine whether bacteria function as clones or as complex mixtures of strains at micrometer scales, and will develop a new method for micrometer-scale imaging of the dynamics of multitaxon bacterial communities.